Imaging and Image Analysis Core

PROJECT SUMMARY: IMAGING AND IMAGE ANALYSIS CORE
The Imaging and Image Analysis Core fulfills the fundamental needs of investigators for microscopy, live cell
and in vivo imaging, and image processing and analysis. It provides equipment and expertise that will increase
innovative capabilities and creates an environment that promotes productive collaborative basic and
translational vision science research. The goals are: 1) to provide equipment for high resolution imaging and
software for image processing and analysis, 2) to assist and/or perform image acquisition using upright,
inverted, fluorescence light microscopes, deconvolution and laser scanning confocal microscopes, spinning
disk live cell imaging system, scanning laser ophthalmoscopy and optical coherence tomography, 3) to assist
and/or perform image processing and analyses obtained by various imaging systems, 4) to assist in
development of basic software algorithms and macros for automated image acquisition, processing and
analysis, and 5) to train investigators and their research staff on the use of available equipment and software.

Public health relevance
NARRATIVE: IMAGING AND IMAGE ANALYSIS CORE The Imaging and Image Analysis Core fulfills the fundamental needs of investigators for use of microscopy, live cell and in vivo optical imaging, and image processing and analysis in vision science research.